Molecular determinants of anti-RBC alloantibody evanescence

Summary. For patients who require chronic transfusion, the generation of antibodies to red blood cell (RBC)
antigens can be a major clinical problem. Anti-RBC antibodies often make finding compatible blood difficult
for these patients, which is particularly unfortunate since these RBC transfusions are often lifesaving. A major
complication arises when these anti-RBC alloantibodies disappear before detection in the blood bank, a
process referred to as evanescence. Patients whose antibodies have disappeared can unknowingly receive
a second transfusion of incompatible blood. This incompatible transfusion can induce a life-threatening event
called delayed hemolytic transfusion reaction. Anti-RBC evanescence therefore directly leads to delayed
hemolytic transfusion reactions, which are a major cause of injury and death in chronically transfused patients.
This is a particularly serious problem for patients with sickle cell disease, who often require frequent
transfusions and have high rates of evanescent antibodies. Despite its clinical importance, the molecular
factors that lead to anti-RBC alloantibody evanescence are completely unknown. Accordingly, there are no
effective therapeutic interventions available to alloimmunized patients other than antigen avoidance. We have
recently made the novel finding that the HOD mouse model of red blood cell (RBC) alloimmunization
recapitulates many of the key clinical features seen in chronically transfused patients. Specifically, we have
shown that HOD RBC transfusion leads to the preferential generation of low-affinity, rapidly evanescent anti-
RBC alloantibodies at the expense of high-affinity, persistent antibodies. Herein we propose to use this mouse
model to investigate why RBC transfusion leads to rapidly evanescent antibodies rather than long-lived ones.
Our central hypothesis is that RBC presentation of antigens directly alters the innate immune responses of
recipients, driving the differentiation of CD4+ T cells into helper cells which are unable to sustain long-lived
interactions with B cells. We hypothesize that though these T cells can drive extrafollicular antibody responses
that produce low-affinity, short-lived antibodies, they are blocked in their ability to drive germinal center
responses that allow for somatic hypermutation, antibody affinity maturation, and long-lived antibody
producing plasma cells. By better understanding how the fundamental cellular and molecular immune
regulators of anti-RBC alloantibodies are regulated over time, we hope to discover novel molecular targets
that can serve as potential future therapeutics for those patients who are at high risk from the complications
of RBC alloimmunization.

Public health relevance
Red blood cell (RBC) alloimmunization remains a common clinical problem for patients who require chronic transfusion. This is particularly true when the antibodies patients make fall below the level of detection, i.e. are evanescent. By identifying the molecular and cellular mechanisms that control RBC antibody evanescence in a mouse model of alloimmunization, this proposal will provide therapeutic and diagnostic targets for further clinical development.